Inflammatory challenge and fear extinction: A model to enhance understanding of posttraumatic stress disorder

PROJECT SUMMARY
Posttraumatic stress disorder (PTSD) is a chronic disorder affecting more than 8% of the general population
and two-three times as many women as men. Deficits in fear extinction, which refers to the learned inhibition of
fear responses, and fear extinction recall, which refers to the retention of this learned inhibition over time, play
a critical role in PTSD. Interventions that target fear extinction learning are first-line treatments for PTSD, but
they are only partially effective. To develop new and enhanced interventions, we need a better understanding
of the factors that influence fear extinction processes in PTSD in both females and males. One such factor is
inflammation, which is elevated in response to acute psychological stress and in PTSD. Preclinical models
indicate that elevated inflammation in general, and elevated levels of the pro-inflammatory cytokine interleukin-
6 (IL-6) in particular, can impair fear extinction. People with PTSD and women may be more sensitive to the
effects of inflammatory activity on fear extinction. Our long-term goal is to uncover the mechanistic role that
inflammation plays in PTSD in order to identify effective primary and adjunctive anti-inflammatory interventions.
Our objective in this proposal is to determine the effects of acute inflammatory challenge on fear extinction
processes in trauma-exposed women and men with and without PTSD. Our central hypothesis is that acute
inflammatory challenge will impair fear extinction processes, with particularly strong effects in people with
chronic PTSD and women. Our aims are to: 1) determine the effects of acute inflammatory challenge on fear
extinction processes in individuals with and without PTSD; 2) examine if increases in inflammatory activity
mediate associations between acute inflammatory challenge and fear extinction processes; and 3) elucidate
sex differences in the effects of acute inflammatory challenge on fear extinction processes. In our proposed
study, we will use polysaccharide typhoid vaccine, which our preliminary data support as a robust acute
inflammatory challenge, and a fear-conditioning paradigm that we have used in >200 people with PTSD.
Participants will first undergo fear acquisition (i.e., fear learning). Then, three days later, following
consolidation, they will receive either vaccine or placebo; 4.5 hours later, when inflammatory activity is robustly
increased, participants will go through the fear extinction phase of the protocol, and one week later, the
extinction recall phase, with outcomes indexed by the skin conductance response (SCR). Inflammatory
markers will be measured at baseline prior to fear acquisition, pre- and 4.5 hours post vaccine/placebo prior to
fear extinction, and prior to extinction recall. This proposal is significant and innovative because it would be the
first study to examine the effects of acute inflammatory activity on fear extinction processes in trauma-exposed
individuals with and without PTSD, and it has potential to elucidate biological mechanisms of impaired fear
extinction, uncover sex differences, and point us in the direction of novel interventions to treat PTSD.

Public health relevance
PROJECT NARRATIVE Posttraumatic stress disorder (PTSD) is a major public health problem for which current treatments are inadequate. Accumulating preclinical and clinical evidence indicates that acute inflammatory activity impairs fear extinction, which in turn could prevent recovery from PTSD. The proposed research takes a vital first step towards translating this evidence into novel interventions to improve public health by determining the effects of acute inflammatory activity on fear extinction processes in men and women with and without chronic PTSD.